CD45-mediated endothelial-to-mesenchymal transition in cardiovascular disease

PROJECT SUMMARY/ABSTRACT
Atherosclerosis is the primary cause of coronary heart disease, ischemic stroke, and peripheral arterial
disease. This progressive vascular disease remains a leading cause of mortality in the United States despite
wide-spread use of effective lipid-lowering therapies and prevention programs. While endothelial cell activation
and neointimal hyperplasia is a hallmark of the initiation and progression of atherosclerosis, identification of
molecular markers of dysfunctional endothelium represents a biological challenge as well as an opportunity to
develop new therapeutic targets. In this application, we posit to explore the function of endothelial expressed
CD45 in atherosclerosis. CD45 is best known as marker of hematopoietic cells. Our recent data shows that
CD45 is indispensable in driving the endothelial-to-mesenchymal transition (EndMT) following myocardial
infarction. It is thought that EndMT represents a novel endothelial perturbation and a critical regulator of
atherogenesis given that EndMT disrupts the normal function of endothelium by delaminating endothelial cells
and giving rise to neointimal mesenchymal cells, which secrete proinflammatory molecules and extracellular
matrix proteins that fuel atherosclerosis progression. Whether endothelial CD45 contributes to progression of
atherosclerosis by facilitating the EndMT is a completely unknown but highly significant question. In our latest
studies, we showed CD45 null mice injected with the atherosclerosis accelerator PCSK9 AAv8 and fed a
western diet had a marked reduction in atherogenesis. Conversely, we observed a significant increase in CD45
positive endothelial cells (ECs) that undergo the EndMT in atherosclerotic lesions. We also found that
CRISPR/Cas9-mediated activation of CD45 in human ECs induces the EndMT. Intriguingly, CD45 expression
is dramatically increased in HDAC2 knockout hemogenic endothelium, suggesting loss of HDAC2-mediated
repression of CD45 during EndMT. Further, CD45 expression is altered in miR-155 deficient mice, indicating
microRNAs may regulate the expression and function of CD45 during EndMT. Our pilot RNA seq study shows
upregulation of epsins and downregulation of KLFs upon CD45 overexpression. Given that epsins promote and
KLFs impede atherosclerosis, whether CD45 induces EndMT and promotes atherosclerosis by modulating
epsin and KLF function is an entirely novel question. To test this, we will determine the role of endothelial
CD45 in regulating atherosclerosis in vivo and interrogate molecular mechanisms 1) by which endothelial
CD45 regulates EndMT in atherosclerosis by controlling epsin and KLF expression and 2) underlying how
CD45 expression is epigenetically regulated in ECs during EndMT and whether targeting endothelial CD45
promotes atheroma resolution. Our preliminary data presents robust evidence that serves as a strong scientific
premise for our proposed study. If successful, our study will not only provide extensive mechanistic evidence
for a central role of CD45-mediated signaling in regulating the EndMT, but will provide an innovative approach
for the treatment of atherosclerosis and launch a paradigm shift in research to combat cardiovascular disease.

Public health relevance
PROJECT NARRATIVE This proposal focuses on the molecular mechanisms that underlie initiation and progression of atherosclerosis, which is a leading cause of death worldwide and highly relevant to the mission of the NIH. We will focus on studying a master regulatory protein that controls the endothelial-to-mesenchymal transition — a biological process that facilitates development of atherosclerotic lesions and accelerates destabilization of plaques, resulting in heart attacks and stroke. We anticipate the study of this pathological process will identify biological pathways that can be exploited as therapeutic targets.